BIOLOGICAL DEFINITION OF HOST DEFENSE DEFECTS IN MAN

The major goals of our studies are to investigate the process of normal differentiation and maturation of lymphoid cells and to use this basic knowledge to define the defects in lymphoid cell differentiation or lymphocyte function that are associated with or responsible for immune deficiency diseases, lymphoid malignancies, and disorders of immunoregulation.